Investigating Novel Genetic Variants that Confer Susceptibility to Pesticide-induced Parkinson's Disease

PROJECT SUMMARY/ABSTRACT
Exposure to various pesticides has been established as an environmental factor that increases risk of
Parkinson’s disease (PD). The biological impact of environmental risks is largely dependent on genetically-
determined factors, but identifying these genetic factors through purely epidemiological studies is complicated
both by genetic heterogeneity and uncertainties about lifelong pesticide exposure levels. This proposal aims to
provide biological validation of novel candidate gene variants associated with increased susceptibility to
pesticide-induced PD. We have identified candidate gene variants based on analysis of the FAME study
database, which includes detailed clinical and pesticide exposure data from 493 agricultural workers of whom
100 developed PD. The novel gene candidates were identified using whole genome sequencing and gene
burden analysis stratified across all of the pesticide exposure groups as well as for each individual group
(paraquat, rotenone, permethrine, dieldrin). In this proposal we aim to biologically validate the importance of
these variants using two complementary systems: iPSC-derived human dopaminergic neuronal cultures and a
mouse model of paraquat-induced Parkinsonism. Candidate genes will be down-regulated in the human
neuronal cultures using a CRISPRi approach and upregulated using lentiviral vectors to determine effects of
gene expression on pesticide-induced cell death, oxidative stress, DNA damage, and mitochondrial
morphological alterations. In parallel, genes of interest will be down-regulated or up-regulated in mouse
substantia nigra using viral vectors in order to determine if dopaminergic susceptibility specifically to paraquat is
influenced by these genes in the intact sustantia nigra of live animals. Success in these studies will both identify
novel genetic variants and gene targets that influence dopaminergic susceptibility to pesticide toxicants and
establish a platform for evaluating of other candidate gene variants and toxicants.

Public health relevance
PROJECT NARRATIVE The genetic variants that determine susceptibility to pesticide-induced Parkinson’s disease are largely unknown. We have identified candidate genes based on burden analysis on whole-genome sequencing performed on samples acquired from the FAME study database, which includes detailed clinical and pesticide exposure data from agricultural workers. Here we aim to biologically validate the importance of these genes using two complementary systems: iPSC-derived human dopaminergic neuronal cultures and a mouse model of paraquat- induced Parkinsonism.